Summer Scholars in Genome Sciences & Medicine

SUMMARY
Students interested in pursuing a career in genome sciences and medicine research will require a strong
foundation of core genome sciences technology, analytical skills, and inter-disciplinary training. The
overarching goal of this renewal application is to continue to provide a high-quality mentored research
experience for promising students in the rapidly growing area of genome sciences and precision medicine. The
10-week summer program centers around a mentored research project in genome sciences and medicine,
supplemented with didactic and interactive training, research seminars and career development skills-building.
The program is open to all under-represented students in science, technology, engineering and mathematics
who are rising sophomores and juniors. In this renewal, we are expanding our current partnership with North
Carolina Central University (NCCU), an historically black college and university (HBCU), to include three
additional HBCUs in North Carolina to create a core network of students for the summer program. Faculty
mentors for this program span a wide range of disciplines in basic and applied genome sciences, data
sciences, translational genomic medicine, bioinformatics and computational biology, engineering, and
statistics. The research experience will be complemented by a series of research seminars by faculty at Duke
and HBCU partners, and visits to sequencing facilities and companies using genome sciences technologies or
data in their research in nearby Research Triangle Park, and other science-related community service
activities. Given the increased recognition of the importance of data sciences, we are proposing to incorporate
more learning opportunities on data sciences specifically to introduce students to some of these tools and work
with open access datasets. In addition, students will have the opportunity to consider broader issues impacted
by their research through a weekly discussion on the ethical, legal, social, and policy issues and gain important
skills such as critical reading of scientific papers, leading a discussion group, conducting literature reviews, and
making formal presentations. All students will be required to present their research at the conclusion of the
program. We will administer annual surveys to summer scholars to gather information about their educational
and career paths in STEM as a measure of the training program's impact. To date, this R25 program has
supported 24 students over four summers (no students were accepted in summer 2020 due to Covid
restrictions); a majority of students were female and African-American. Several students have successfully
continued on in research throughout their undergraduate career and been accepted into leading graduate
programs and medical schools around the country. With the proposed changes in this renewal application and
our expanded partnerships with other HBCUs in the region, we hope to be responsive to the rapidly changing
science and required skillsets and to increase awareness and recruitment for the program. In summary, we
aim to continue to offer under-represented students a rich and highly interdisciplinary research experience in
genome sciences and medicine.

Public health relevance
PUBLIC HEALTH RELEVANCE The purpose of this grant is to provide under-represented minority undergraduate students with an opportunity to work on an mentored research project in genome sciences or medicine, supplemented with training in the core genome sciences and ethical/legal/social issues, and to develop essential research skills including conducting a literature review, critical reading of scientific literature, and oral and written presentations. The students supported by this grant will gain the necessary knowledge and experience to continue their educational training in a research-oriented path in science, technology, or mathematics.